A liquid cathode for medical imaging X-ray sources

PROJECT SUMMARY
It is generally agreed that the development of distributed X-ray sources (i.e., systems having multiple X-ray
sources contained within a single vacuum envelope) could fundamentally improve tomographic medical X-ray
imaging technology by removing the need for mechanical motion of the X-ray source. Removing such motion
provides the potential to develop more compact, higher-speed, and lower-cost X-ray imaging systems with
better image quality, new imaging modalities, and more widespread system availability. The net result would
be to make imaging systems with greater capabilities more widely available to a larger number of people. A
significant impediment to achieving this result has been the lack of an appropriate cathode (electron emitter)
technology for the distributed X-ray source.
This grant application proposes to explore a very different approach to cathodes for medical X-ray imaging
sources: a liquid cathode. This unique cathode uses an electrohydrodynamic instability to form field electron
emitting sites on the surface of a liquid metal with Faraday waves, induced by slight mechanical vibration of the
fluid by a piezoelectric transducer. Because the cathode is a liquid, it is self-healing, which will mitigate failure
mechanisms associated with field emission cathodes used to date, thereby resulting in high reliability and long
life. By distributing the resulting compact electron source elements in space, the X-ray focal spot distribution
can be changed, i.e., reconfigured electronically, in real time. This approach has the potential to shift the
paradigm of medical X-ray imaging systems by combining a reliable, long-lived, and robust source with an
electronically reconfigurable X-ray focal spot distribution.
The specific aims of this proposal focus on experiments to determine whether the liquid cathode approach has
the performance characteristics required for medical imaging applications. The aims are:
Aim 1. Fabricate liquid cathode testbed
Aim 2. Quantify electron emission characteristics of liquid cathode
Aim 3. Quantify X-ray emission characteristics of liquid cathode-based source
Aim 4. Develop preliminary liquid cathode-based designs for several widely used medical imaging applications

Public health relevance
PROJECT NARRATIVE This research on a new approach to X-ray sources—removing the need for mechanical motion of the source by way of a unique liquid cathode—could help initiate the development of medical X-ray imaging systems with better image quality that are also more reliable, more compact, faster, and less costly than existing systems. Combined, these improvements could improve human health by enabling imaging systems with greater capabilities and making them more widely available.